Coronary Fractional Flow Reserve Determined Using MRI and CFD

Project Summary
The primary interventional treatment for ischemic coronary artery disease (CAD) is percutaneous
intervention (PCI) involving angioplasty and deployment of a vascular stent. Clinical trials have shown that
fractional flow reserve (FFR), which is assessed by taking the ratio of pressure distal to the stenosis divided by
pressure proximal to the stenosis, reduces the number of adverse cardiac events compared to the use of
angiographic-based anatomical criteria alone. Despite its benefit, invasive measurement of FFR is not widely
used due to its high expense and procedural complexity.
Magnetic resonance imaging (MRI) combined with computational fluid dynamics (CFD) offers a method
for determining FFR non-invasively and without ionizing radiation. MRI can be used for coronary artery imaging,
can measure coronary flow, is non-invasive, and does not use ionizing radiation. Therefore, our first objective is
to develop, validate, and test a cardiac MRI-based method to determine coronary FFR (FFRMRI). We will team
with the Siemens Healthineers MRI collaboration division to develop and test new image acquisition and
reconstruction methodology, and team with the Siemens Healthineers Medical Imaging Technology division to
develop image processing methods and display technology. The new paradigm will be tested in healthy controls
and in models studies, then applied to a group of subjects with stable CAD.

Public health relevance
Project Narrative This project will create a new non-invasive methodology to measure coronary fractional flow reserve (FFR) based on magnetic resonance Imaging (MRI) and computational fluid dynamics (CFD). FFR a metric to assess the functional severity of coronary lesions and treatment decisions based on FFR rather than angiography severity have been shown to improve patient outcomes. Image acquisition and image display methodology will developed in conjunction with the Siemens Healthineers Medical Imaging Technology and MRI Collaboration Divisions.